Neural dynamics and substrates of graphical knowledge

Project Summary/Abstract
The ability to use explicitly structured internal models of the world is both central to biological intelligence and
impaired in disorders of cognition (e.g. dementia and schizophrenia). Recent work indicates that cognitive
abilities such as declarative memory and navigation rely on internal models having the structure of graphs,
i.e. composed of rules and variables. Such graphical knowledge structures, or ‘schemas,’ are now thought to
be what enable humans and animals alike to make extraordinary and systematic inferences, to generalize, to
learn in single trials, and to imagine: thus schemas are understood to be basis of advanced cognition. Still,
despite this vital importance, little is known about how neurons in the brain implement schemas. Solving this
overarching problem is my scientific goal, and the aim of the present proposal.
In recent work, I have discovered a collection of recurrent neural networks (RNN) – neural systems that are
plausibly implemented in the brain – that can perform three cognitive tasks requiring schemas: transitive
inference (TI), associative inference (AI), and identity rule inference (IRI). Importantly, these tasks are
potentially more tractable alternatives to traditional schematic tasks in neuroscience: indeed, initial analyses
indicate that RNNs use a solvable set of dynamical mechanisms to implement schemas, and are thus
mechanistic hypotheses that have not previously existed in neuroscience. Given these findings, I hypothesize
that these candidate mechanisms are used in hippocampus (HPC) and prefrontal cortex (PFC), two brain
regions required for schemas. To test this guiding hypothesis, I will solve and characterize the mechanisms
accomplishing AI and TI (Aim 1) and IRI (Aim 2) in RNNs (K99), then probe mechanisms experimentally via
high-density recordings in the HPC and PFC of rats performing these tasks in an innovative olfactory-based
paradigm (Aim 3) (R00). Achieving these Aims has the potential to establish how schemas are implemented
in the brain, and therefore can clarify the neural basis of advanced cognition; this work can also clarify
computational and behavioral roles of HPC and PFC, two brain structures essential to cognition.
The K99 phase of this work will be done in the Zuckerman Institute for Brain and Behavior at Columbia
University under the mentorship of Larry Abbott and John Cunningham, two leading authorities who will
advise on neural modelling, dynamical systems, and advanced machine learning; in addition, collaborators
(Drs. Stefano Fusi, Vincent Ferrera, Daphna Shohamy, Rui Costa, and Richard Axel) will contribute scientific
and technical expertise on cognitive tasks (design and neurobiological interpretation) and neural recordings.
The training environment also includes the wider innovative and collaborative neuroscience community at
Columbia, the Columbia Center for Theoretical Neuroscience, and their associated scientific and career
development opportunities. Training in the K99 phase will be crucial for both the proposed research and for
establishing future scientific and professional independence as an investigator leading a research group.

Public health relevance
Project Narrative Our cognitive abilities define us, and disorders involving cognitive impairment (including dementia, schizophrenia, and autism) are both debilitating and widespread. Recent scientific advances indicate that many of our most vital cognitive abilities (including memory, reasoning, planning, and creativity) rely on a form of knowledge that has the structure of graphs – yet despite this insight, we still do not know how graphical knowledge is implemented by neurons in the brain. This proposal aims to solve this problem by combining two powerful complementary approaches: (i) neural network models and (ii) experimental analysis of neural activity in animals (rats) that have acquired graphical knowledge.